Non-invasive characterization of human soft tissue sarcoma response to radiation therapy

PROJECT SUMMARY/ABSTRACT
Everett Moding, MD, PhD is an Assistant Professor of Radiation Oncology at Stanford University School of
Medicine. His long-term goal is to use his combined expertise in clinical and research medicine to make important
discoveries in radiation and cancer biology that lead to better treatments for patients with sarcomas. He hopes
to develop a translational research program using analysis of human tumor and blood samples to identify critical
mediators of radiation resistance that can be validated in preclinical models and leveraged to enhance the
efficacy of radiation therapy.
The goal of this career development award is to provide support and mentorship to enable Dr. Moding to
develop a successful independent research program. The proposal will be carried out under the mentorship of
physician scientists Maximilian Diehn, MD, PhD, an expert in genomicsbased biomarkers, Ash Alizadeh, MD,
PhD, an expert in tumor immunology and transcriptomic analysis tools, and David Kirsch, MD, PhD, a leader in
radiation biology and mouse models. The training plan incorporates formal coursework, seminars, conferences,
and programs along with informal hands-on and practical activities to expand Dr. Moding’s knowledge and
expertise in 1) computational and systems biology, 2) tumor immunology and sarcoma biology, and 3) laboratory
management, mentoring, and grantsmanship.
Soft tissue sarcomas (STS) are a diverse group of mesenchymal tumors primarily managed with surgery and
radiation therapy for localized disease. Although half of patients with high risk STS develop metastatic disease
after initial therapy, there are no biomarkers to identify patients at risk of relapse. In addition, up to two-thirds of
patients with STS develop local recurrences after radiation therapy alone, but the underlying genetic alterations
that mediate radiation resistance are unknown. By analyzing tumor and peripheral blood samples collected from
102 patients enrolled on the SU2C-SARC032 phase II clinical trial, this research proposal aims to 1) establish
personalized circulating tumor DNA analysis as a biomarker in patients with STS, 2) build a prognostic model
integrating tumor microenvironment profiling, circulating tumor DNA analysis, and traditional risk factors to
improve prediction of patient outcomes, and 3) use circulating tumor DNA analysis and tumor sequencing to
identify genetic alterations that mediate the response of sarcomas to radiation therapy for rapid functional
validation in novel preclinical platforms. This proposal will lay the groundwork for future prospective randomized
trials using circulating tumor DNA analysis and tumor genomics to enable personalized treatment approaches in
patients with STSs that improve the probability of tumor eradication while minimizing treatment-related toxicity.

Public health relevance
PROJECT NARRATIVE Although half of patients with soft tissue sarcoma develop distant metastases after radiation therapy and surgery, there are currently no biomarkers to identify patients who would benefit from adjuvant systemic therapy and no known genetic alterations that mediate soft tissue sarcoma response to radiation therapy. We propose to use circulating tumor DNA analysis to identify patients at high risk of relapse who could benefit from additional therapy and discover genetic alterations that mediate radiation response. This work will lay the foundation for future clinical trials incorporating circulating tumor DNA analysis and tumor genomics to personalize treatment approaches and improve outcomes in patients with soft tissue sarcomas and other malignancies treated with radiation therapy.